Adapting and Implementing the Indigenous informed intervention Wa' Kan ye' zah to reduce stress and promote wellbeing and resilience in Tribal Head Start Teachers, Fort Peck reservation, Montana

Project Summary:
Teaching is ranked as one of the most stressful occupations in the U.S. with 46% of teachers reporting
high daily stress during the school year. Teacher burnout, anxiety, depression, sleep disorders, poor
performance and a high turnover rate have all been attributed to teacher stress and is estimated to cost more
than $7 billion a year for our economically burdened US public education systems. Head Start is a national
program designed to help break the cycle of poverty, providing preschool children of low-income families with a
comprehensive program to meet their emotional, social, health, nutritional and psychological needs. It includes
34 American Indian and Alaska Native Head Start programs, which serve 44,000 children of American Indian
heritage.
Head Start teachers in remote Native American reservation settings are from the community, with more
than twenty five percent reporting significant prior trauma exposure. With limited skills or support to cope with
the stress of meeting the complex needs of the children and their families in this setting, the challenges for
teachers can be immense. Reservation communities suffer more severe health disparities, often linked to the
powerful effect of social determinants of health. Additionally, high rates of adverse childhood experiences
(ACE), including discrimination, poverty and trauma are associated with violence, chronic disease, risk
behavior and mental health outcomes. Head Start administration at Fort Peck reservation, Montana has
requested that an intervention be implemented to help their teachers deal with stress and support them as they
deal with children, and families struggling with poverty, severe health disparities, and mental health issues.
The proposed mixed methods clinical trial research experience(CTRE) builds on the research
infrastructure of ongoing NINR funded trial, Wa’Kan Ye’ Zah (R01MH115840) which is a randomized
controlled trial to test the effectiveness of the Wa’Kan Ye’ Zah intervention with parent/child dyads enrolled in
Tribal Head Start at Fort Peck. The proposed CTRE under the guidance of the applicants sponsors will focus
on the Fort Peck teachers and use exploratory mixed methods to AIM 1: Explore Tribal Head Start teachers
needs and expectations for a culturally appropriate intervention that promotes resilience, minimizes stress and
strengthens capacity to implement Tribal Head Start program. AIM 2: Integrate findings from AIM 1 with Tribal
Advisory Board and theater testing to co-design an adaption of the existing 4 cultural components of Wa'Kan
Ye'Zah that is tailored to the needs of Tribal Head Start teachers. AIM 3: Examine feasibility and acceptability
of prototype with sample of Tribal Head Start teachers
. This study is consistent with NINR’s strategic goal of
improving wellness by promoting health and preventing illness. Findings will provide the basis for future studies
with the national Tribal workforce with the goal of improving the health and well-being of the entire community.

Public health relevance
Project Narrative: Native American reservation communities suffer severe health disparities, high rates of adverse childhood experiences (ACE), including discrimination, poverty and trauma which are associated with violence, chronic disease, risk behavior and mental health outcomes. Head Start teachers that work on isolated Native American reservations with pre-school children are in need of culturally appropriate behavioral interventions to help support them to manage their stress and cope with the complex issues facing their students, families and communities. The purpose of this clinical trial research experience study is to adapt and test the feasibility and acceptability of the culturally appropriate behavioral intervention Wa’Kan ye zah as a model for reducing stress and promoting wellbeing in Tribal head start teachers.